Project 2 - Post-transcriptional mechanisms and the HSV lytic/latent balance

Summary/Abstract – Project 2
The long-term objective of this project is to investigate how post-transcriptional gene regulatory mechanisms tilt
the interaction of herpes simplex virus (HSV) with neurons either towards lytic infection or towards latency.
HSV latency is the most fascinating biological property of the virus and its most important clinical feature.
Understanding HSV latency may lead to new therapies or even a cure for this widespread pathogen. The first
specific aim of this project is to investigate repression of lytic gene expression during latency. At least one
microRNA (miRNA), host miR-138, represses lytic gene expression and promotes HSV latency, but much
remains unknown about how this or other miRNAs impact HSV infections. The roles of miR-138, miRNAs more
generally, and miRNAs from the latency associated transcript (LAT) locus will be investigated using mice
whose miR-138 or Dicer genes can be inducibly excised in sensory neurons. Effects of such conditional
knockouts on viral replication and reactivation, viral gene expression, chromatin status, and latency will be
measured in vivo and, in collaboration with Projects 1 and 3, in cultured neurons. Two specific hypotheses
regarding how products of the LAT locus repress ICP4 gene expression will be tested. With Project 1, a
hypothesis regarding transcription antisense to the ICP4 gene or the corresponding transcripts will be tested
using viral mutants that should exhibit decreases in such transcription. The hypothesis that miR-H6 represses
ICP4 expression will be tested using mutants with disrupted miR-H6 expression or binding sites for it. The
second specific aim focuses on post-transcriptional – most likely translational – mechanisms restraining
expression of the viral protein ICP34.5 that counteracts host immunity. How mutations affecting the 5'
untranslated region of ICP34.5 mRNA increase ICP34.5 expression and viral virulence will be studied, and,
with Project 3, their effects on immune mechanisms will be assessed. The third specific aim assesses a post-
transcriptional mechanism that may tilt the balance towards lytic infection. How HSV-1 blocks miRNA
biogenesis by preventing export of miRNAs from the nucleus during lytic infection, which may overcome
repressive functions of latent miRNAs, will be studied. The viral gene product(s) responsible will be identified
by testing HSV-1 open reading frames from Project 1 and viral miRNAs for blocking pre-miRNA to miRNA
conversion in miRNA-transduced cells, and by testing viral mutants. How the gene product(s) cause this
blockade will be investigated. The fourth aim seeks to identify targets for miRNAs from the LAT locus by using
deep sequencing based methods. Candidate targets will be tested for their roles in HSV replication and other
biological activities in collaboration with Projects 1 and 3. Throughout this project, studies of gene expression
and chromatin status will be assisted by Core A, and studies using mice will be assisted by Core B.